Early detection of cancer using extracellular vesicle-based liquid biopsy enhanced by priming agents

Project Summary
Cancer is one of the leading causes of death, attributed to nearly 10 million deaths per year worldwide,
and its growing incidence represents a significant global health issue. Early detection of cancer is one of the
most significant clinical interventions that improve clinical outcomes in patients with cancer. Blood biopsy-based
tests are a promising frontier for detecting molecular-level information of cancers in a minimally invasive way.
One common blood biopsy analyte is circulating tumor DNA (ctDNA), for which tests have been developed for
detection of various DNA-level features. However, ctDNA-based tests are incapable of providing molecular
information past DNA-level changes, such as changes in transcriptome, protein expression, or cell population,
which are all often important for clinical decision making. Tumor-derived extracellular vesicles (tEVs) can carry
a variety of biomarkers, including mRNA, and are potentially powerful liquid biopsy analytes to provide
information on transcriptional and expression status of cancers. Yet tEVs, like other liquid biopsy analytes, face
challenges of low abundance and tumor fraction, which limit their clinical use. To address this, our lab has
recently shown that administration of nanoparticle “priming agents” can transiently delay clearance of ctDNA,
increasing its abundance in circulation and the sensitivity of ctDNA-based diagnostic tests.
The overarching goal of the proposed work is to test whether priming agents can increase
recovery of tEVs from blood biopsy and thus improve the sensitivity of tests based on tEV-derived mRNA
(tEV-mRNA) quantification. Aim 1 will develop novel priming agents targeting different EV markers involved in
the uptake of EVs to delay their clearance. This will be accomplished through in-house formulation of priming
agents, and studying the activity of these priming agents using in vitro models and in vivo models with
exogenously delivered fluorescent EVs. Aim 2 will demonstrate that our novel priming agents can increase
tumor-derived EV recovery from multiple in vivo cancer models. Aim 3 will characterize the effect of priming
agents on quantification of clinically-relevant gene transcripts from tEV-mRNA. A custom digital droplet PCR
assay will be established to quantify copy number of transcripts for key genes expressed in breast and prostate
cancer. This work has the potential to realize novel paradigms for methods for early detection of cancer and to
lay the groundwork for minimally invasive blood biopsy tests to detect and monitor cancer at the transcriptome
level across a wide variety of cancer types.

Public health relevance
Project Narrative Tumor-derived extracellular vesicles (tEVs) are a class of blood biopsy analyte which holds great promise in providing information on transcriptional and expression status of cancers, enabling minimally invasive detection and monitoring of cancer to improve clinical management, yet tEVs are limited in their use due to their low abundance from blood. Priming agents have been demonstrated to transiently delay clearance of circulating tumor DNA (ctDNA) to increase its abundance in circulation and the sensitivity of ctDNA-based tests. The proposed research will explore whether priming agents can increase recovery of tEVs from liquid biopsy, which can then be used to increase the sensitivity of tests quantifying gene expression based on detection of tEV-derived mRNA.